High Resolution Mapping of Functional Elements in the Yeast Genome

The budding yeast Saccharomyces cerevisiae is used as model system to understand genomic mechanisms by
which chromatin organization is established. The start sites of genes, or promoters, are typically encased in a
nucleosome-free region, that is bookended with two well-positioned nucleosomes. This precise organization is
standard for most genes, and plays into how these genes are regulated. Therefore a fundamental
understanding of gene regulatory mechanisms requires a complete understanding of how such canonical
nucleosome organization arises and guides the placement of the transcription machinery. The proposed work
will take advantage of biochemical reconstitution of aspects of canonical nucleosome organization on a
genomic scale. This will allow individual mechanistic contributions of chromatin organizing factors and their
effectors to be explicitly defined. In particular, how ATP-dependent chromatin remodeler complexes recognize
DNA features and sequence-specific organizing factors, will be addressed. The organization of chromatin
directs the organized assembly of the transcription machinery. Biochemical reconstitution will be used to tease
apart selected individual contributions of chromatin organization and activator/repressor binding towards
assembly of the transcription machinery on a genomic scale. Chromatin is generally thought to be composed of
nucleosome particles containing 2 copies of each of the four core histones. However, it is now becoming clear
that various partially assembled nucleosomes or subnucleosomes exist in vivo, and these structures may play
critical roles in chromatin dynamics. The existence of these substructures and the histone chaperones that are
likely to be involved in their assembly and disassembly will be investigated on a genomic scale.

Public health relevance
Yeast is a simple model for understanding complex biological systems including humans. Chromatin, which is the protein/DNA manifestation of eukaryotic genomes, controls cellular behavior and ultimately organismal health. Therefore understanding how cell define chromatin organization (the arrangement of proteins) on DNA will inform us about how genes are regulated and mis-regulated in disease.